Global Center on Climate Change and Water Energy Food Health Systems

OVERALL ABSTRACT
Climate change is the greatest global health threat of this century, yet health is not central to research in low and
middle income countries that are going to be impacted the most. Adaptation to this threat will create climate-
resilient communities and prepare them for climate change extreme events and the long-term impacts. Among
the regions across the globe, the Middle East is going to be the epicenter of this impact given a multitude of
factors exacerbating the climate change health impacts such as being the most water scarce-region, the region
with the highest records of extreme heat, extreme disparity between very poor and very affluent communities,
as well as political instability in many of the countries of the region. In that region, Jordan is ranked second in
the list of countries with lowest water access and is expected to reach water insecurity by 2030. Within that
country, the most water deprived communities live in the Northeast region of Mafraq’s Azraq Basin which is also
home to close to 120,000 resettled Syrian refugees that are dependent on the same water resources. Jordan is
one of the few politically stable countries in the region, and is aggressively looking for solutions to the water
crises in the context of the Water-Food-Energy-Environment nexus and therefore created a high profile
governmental committee to develop policies that can address this crises in the short and long-terms. This is why
we are proposing the Global Center on Climate Change and Water Energy Food Health Systems (GC3WEFH)
to initiate an exploratory phase in Jordan by bringing together scientists with complementary expertise, but
diverse perspectives, to address impacts of climate change on water, energy, food, and health systems in the
climate-vulnerable communities of the Azraq Basin in Jordan. We will pilot feasible solutions focused on
improving health outcomes and in collaboration with the communities that are negatively impacted by climate-
related water scarcity. We will involve the communities, local academics, and public officials in capacity building.
This network and exploratory phase will become the platform for scale up to other interventions and other
countries and regions around the globe. We will demonstrate the utility of engaging vulnerable communities
through the systems of Water-Energy-Food-Health. This will be help them explore trade-off decisions to improve
adaptation to climate change health impacts, in and this pilot phase, through access to sufficient and good quality
water in the Azraq Basin.

Public health relevance
Projective Narrative Climate Change is an existential threat and the biggest global health problem of our century. To address its health impacts, new approaches of thinking of systems of science rather than each science on its own and bringing in diverse scientists to collaborate on finding solutions of climate change health impacts among the most vulnerable global communities. Our proposed center will fulfil that perspective and explore applications of such new approaches in the country of Jordan through water scarcity and health in vulnerable communities in the context of the inter-relation of the Water-Energy-Food-Health nexus and climate change.